The role of brain arousal in resting-state functional MRI

Project Summary
Resting-state functional magnetic resonance imaging (rsfMRI) is being widely used to measure
functional connectivity and dynamics of large-scale brain networks in both healthy subjects and patient groups,
despite the neural bases of rsfMRI-based connectivity/dynamics measures remain largely unclear. Converging
evidence has suggested the contributions from arousal-related factors given large rsfMRI changes seen across
distinct brain states, however, a systemic understanding of the role of arousal factors in rsfMRI research is
missing. The lack of this knowledge hampers the correct interpretation and proper use of rsfMRI-based
measures of brain connectivity and dynamics. To bridge this critical gap, the major goal of this application is to
develop an arousal measure based on spatiotemporal fMRI dynamics and then use it to elucidate and control for
the influences of the arousal on rsfMRI-based measures of brain connectivity and dynamics. The research
objective will be achieved through three specific aims. Aim 1 is to map spatiotemporal fMRI dynamics associated
with a recently discovered event of arousal modulation and utilize this information to improve fMRI-based
arousal measure. The working hypothesis is that transient arousal modulations are associated with a specific
sequence of fMRI activations, and this spatiotemporal dynamic can be utilized to greatly improve fMRI-based
arousal measurements. Aim 2 is to assess the contribution of arousal-related fMRI changes to the relationship
between rsfMRI connectivity and non-neuronal signals, including physiological signals and head motions. It is
hypothesized that the arousal modulation mediates spurious relationships between rsfMRI connectivity and the
non-neuronal noise. In Aim 3, the contributions of arousal factors to rsfMRI-based quantifications of brain
dynamics and their correlations with behavioral measures will be assessed. The working hypothesis is that the
arousal effects on rsfMRI dynamics can be decomposed into the “state” and “trait” effects that have preferential
impacts on the sensory/motor brain areas and higher-order cognitive networks respectively. The arousal “trait”
related to intrinsic individual difference in arousal regulation mediates a part of correlations between certain
aspects of rsfMRI dynamics and human behavior. The proposed research is innovative because it will combine
local experiments and big data analyses to systemically study the direct effect of arousal modulations on rsfMRI
connectivity and dynamics, as well as indirect effects of mediating their correlations with physiology and
behavior. It will also focus on spatiotemporal brain dynamics at transient arousal modulations and utilize this
information for an fMRI-based arousal measure. The impact of this research is significant because a clear
understanding of the effects of the arousal on rsfMRI-based connectivity/dynamics measures is critical for
proper interpretation and correct use of these metrics. An accurate fMRI-based arousal measure is not only
important for controlling the arousal effects and thus improve rsfMRI-based quantifications but also for future
neuroimaging studies that are interested in the arousal and its role in various brain diseases.

Public health relevance
Project Narrative Resting-state functional magnetic resonance imaging (rsfMRI) has been widely used to chart functional connectivity and dynamics of large-scale brain networks in both patient groups and healthy populations. The major goal of this project is to develop a rsfMRI-based arousal measure and elucidate the contributions of arousal-related factors to rsfMRI-based connectivity/dynamics measurements. The proposed research is relevant to public health because the outcomes are expected to improve the rsfMRI tool for noninvasive quantifications of brain connectivity and dynamics and promote its applications in various brain diseases.